Eunice Kennedy Shriver NICHD Maternal Fetal Medicine Units Network (U10)

DESCRIPTION (provided by applicant): This application describes the qualifications and experience of the maternal-fetal medicine faculty and research team at the University of Texas Southwestern (UT Southwestern) Medical Center and Parkland Hospital and the facilities and patient population available to carry out clinical protocols sponsored by the NICHD Maternal-Fetal Medicine Units (MFMU) Network. UT Southwestern's Division of Maternal-Fetal Medicine includes 16 full-time faculty physicians certified in maternal-fetal medicine. In 2009, there were 14,275 obstetrical patients delivered at Parkland Hospital and approximately 49% were high-risk. Pregnancy complications of particular interest to the MFMU Network, for example, preterm birth and preeclampsia, are well represented in the obstetrics population at Parkland Hospital. A computerized perinatal database for births at Parkland Hospital, operational since 1982, continues to be a centerpiece in our center's academic productivity as well as an important component of our center's successful participation in the MFMU Network. Indeed, for the past 15 years, UT Southwestern's MFMU Network center has frequently been the first or second leading recruiter for Network protocols. In this last 5 year cycle, our center led the implementation of the randomized trial of thyroxine therapy for subclinical hypothyroidism or hypothyroxinemia diagnosed during pregnancy (TSH) study which successfully screened more than 97,000 women in 3 years. Our center alone screened 18,296 of these women. We have been active in all aspects of the MFMU Network, including concept proposal, subcommittee participation, and manuscript preparation importantly, the maternal-fetal medicine physicians at UT Southwestern are philosophically dedicated to rigorous controlled trials intended to objectively evaluate principles of obstetrical care consistent with the mission of the MFMU Network. The perinatal research team described has been actively involved with and committed to the MFMU Network for the past 15 years and seeks to continue this collaboration.